Mechanisms of fasting-induced radioprotection of small intestinal epithelial cells

Project Summary
We demonstrated that short-term fasting protects mice from high dose ionizing radiation by protecting small
intestinal (SI) stem cells, thereby preserving SI homeostasis and promoting organismal survival. We also
showed that the major ketone body produced by fasting directly modifies the epigenome of SI epithelial cells to
induce gene expression changes and that fasting alters the gut microbiome to favor bacteria whose
metabolites are known to induce epigenetic and gene expression changes. We will test the hypothesis that
ketone bodies and microbial metabolites induced by fasting, cause epigenetic and gene expression changes in
SI epithelial cells thereby providing GI radioprotection.

Public health relevance
Project Narrative Gastrointestinal toxicity often limits the amount of radiation that can be given to cancer patients. Our studies will determine how fasting protects small intestinal epithelial cells from high dose radiation therapy (RT) with the ultimate goal of mitigating deleterious side effects associated with RT so that dose escalation regimens can be employed for efficient tumor cell killing.